Treatment Options for Insomnia for ESRD

Project Summary/Abstract
Patients with end-stage renal disease treated with hemodialysis (HD) report poor health-related quality life, in
part because of the large number of troubling symptoms they experience. One of the most frequently reported
such symptom is insomnia and includes patients' difficulties in falling asleep, frequently waking up after falling
asleep, and early morning awakening. There are unique issues pertaining to HD treatments and schedules that
disrupt regular sleep/wake routines and contribute to the high prevalence and severity of insomnia. A large
body of evidence from HD patients and other populations also indicate that insomnia is associated with fatigue,
daytime sleepiness, pain, depressive symptoms, and a higher risk for death. Despite evidence for broad-
ranging health effects of insomnia, no clinical trials have tested the efficacy of treatments for HD patients.
Cognitive behavioral therapy for insomnia (CBT-I) is recommended as first line therapy but is inaccessible to
HD patients in the United States as they have to commit to thrice weekly dialysis treatments in community-
based dialysis facilities; CBT-I delivered by telehealth can overcome the barriers but its efficacy has never
been rigorously tested for any patient population. Pharmacotherapy is the most widely used treatment for
insomnia for HD patients - while some drugs presently used are unsafe as they are associated with a higher
risk for death for this patient population (benzodiazepines and zolpidem-like drugs), the efficacy of others
(trazodone) has never been tested for HD patients. With this application, we propose to test the short- and
long-term comparative effectiveness of 6-week treatment with telehealth CBT-I, trazodone, or medication
placebo. This will be accomplished with a randomized controlled clinical trial in which 125 HD patients with
chronic insomnia treated in community-based dialysis facilities in Seattle and Albuquerque will be assigned
2:2:1 to telehealth CBT-I, trazodone, and medication placebo, respectively; short-term effectiveness will be
determined at the end of 6-weeks of treatment and long-term effectiveness at 24-weeks. Telehealth CBT-I will
be delivered through a mobile platform, iHOPE, by English and Spanish-speaking therapists. The primary and
secondary patient reported outcomes will be assessed with computer-based telephone interviewing by
research scientists blinded to treatment assignment. The study will be conducted under the oversight of highly
experienced Clinical and Data Coordinating Centers in Seattle with a strong track record of patient enrollment
and retention in clinical trials, and implementing behavioral interventions with high fidelity to the protocol. This
clinical trial will provide the first evidence for the comparative effectiveness of two distinct approaches in
improving insomnia and other patient-reported outcomes for HD patients. It will also be the first rigorous
evaluation of telehealth CBT-I, a readily scalable approach not only for HD patients but also for other patient
populations with difficulty accessing treatment for insomnia.

Public health relevance
Project Narrative Dialysis is a life-sustaining treatment for patients with kidney failure. Yet, most patients experience many troubling symptoms and disturbances in sleep are among the most common reported problem. Research has shown that sleep problems contribute to fatigue, daytime sleepiness, pain, and depression, all troubling symptoms commonly reported by dialysis patients. Yet, there has been no research done to identify what treatments are effective for patients undergoing dialysis with sleep problems. Moreover, dialysis treatments are scheduled three times every week, making it extremely difficult for patients to have the time to receive behavioral therapy – a treatment effective in improving sleep in individuals without kidney failure. In this study, we plan to test the short- and long-term effectiveness of behavioral therapy with a therapist face-to-face delivered over the web, instead of in-person, with a drug. This study has the potential not only to benefit patients treated with dialysis but other patients that have difficulty in accessing treatment for sleep problems.